Development of a comprehensive biodesign curriculum to promote biomedical innovation

Project Summary
The R25 grant will help to solidify the curricular pathway to our undergraduate team-
based biomedical engineering (BME) capstone design courses, and promote student biodesign
skill development during each of the four years of undergraduate education. The specific aim of
this proposal is to provide undergraduate BME students at Stony Brook University with: 1) Early
exposure to biodesign concepts; 2) Continuous training and enforcement in design skill
development; 3) Direct mentorship from clinical and industry mentors, in addition to BME
faculty mentors; 4) Clinical immersion to understand, identify and screen healthcare needs; 5)
Enhanced clinical needs-driven biodesign experience; and 6) A channel to refine and
commercialize promising design products. Biodesign will start in the freshman year, when
concepts of biodesign will be introduced through BME100 (Introduction to BME). In the
sophomore year, BME240 (Emergent Biodesign I, fall semester) and BME241 (Emergent
Biodesign II, spring semester) will be added to the curriculum. Seminars and workshops on
various biodesign topics will be covered, and students will work on team-based design projects.
In the junior year, two more new courses, BME340 (Clinical interaction, fall semester) and
BME341 (Biodesign rotation, spring semester), will be added to the curriculum. In these two
courses, BME students will work with School of Medicine students/faculty on medical
innovation, and then present their innovation ideas to an audience that includes engineers,
clinicians and industry mentors. A selected number of students will participate in a 6-week
clinical immersion program, to generate a list of clinical needs based on their own clinical
observations. In the senior year, these clinical needs will be presented to all the senior students in
BME Capstone design class (BME440/441). Student teams will select a clinical need to focus on
as their senior design project. Design products with commercialization potentials will be carried
on to the 5th-year biotechnology master’s program of BME, and thorough business plans will be
developed. Strong mentorship support will be provided by mentors from BME, School of
Medicine, School of Nursing, and Center for Biotechnology, as well as industry partners. The
proposed educational plan will enable a productive biodesign process that initiates from real
clinical needs. It will also provide students with enhanced biodesign experience, encourage
biomedical innovation, and help the innovation products to reach commercialization.

Public health relevance
Narrative / relevance to public health This project seeks to improve the training of next-generation biomedical engineers and entrepreneurs who will be developing technologies specifically to address unmet clinical needs. By immersing students in a clinical environment, providing them with mentorship from clinicians and industry veterans, and offering them with a pathway for commercializing their designs, we will be improving public health both in the near and long term.